Gradient-Free Quantitative MRI using a Combination of B1-Selective Excitation and Fingerprinting

Project Summary
Magnetic Resonance Imaging (MRI) is one of the most important medical imaging modalities because of its
ability to detect and characterize lesions throughout the body. However, access to MRI is severely limited by its
expensive hardware, complex siting requirements and typically-qualitative images, which require highly skilled
radiologists to interpret. This project proposes a fundamentally new way to encode MRI that could enable sub-
stantially cheaper and more ﬂexible quantitative MRI scanners.
Today the overwhelming majority of MRI scans are encoded using two primary methods: B0 gradients
and parallel imaging using an array of receiver coils. B0 gradients take up a signiﬁcant fraction of the bore diam-
eter; are loud and induce peripheral nerve stimulation, compromising patient comfort; they have relatively long
switching times due to the high inductance of the coils; they require bulky cooling systems and customized am-
pliﬁers; they are expensive, representing 25-30% of the cost of a clinical scanner; and they must be carefully
designed and customized to a scanner's B0 magnet. B0 gradient encoding also suffers from spatial errors due to
concomitant terms, which increase with decreasing B0 ﬁeld strength and will limit the performance of emerging
portable and low-cost MRI systems. Parallel imaging enables scan acceleration by differentiating signals across
large spatial distances, but cannot encode complete images on its own. While some have proposed a third class
of encoding methods using radiofrequency transmit (B1+) gradients, none of the methods described to date have
been translated into clinical use because of practical limits on their performance, stringent hardware requirements
and lack of ﬂexibility in image contrast.
This project will develop and validate a fourth, fundamentally new way to encode MRI based on parallel
transmission using B1+-selective pulses produced by wireless RF coil units with on-coil ampliﬁers that perform
RF transmission and reception, combined with an acquisition and reconstruction process inspired by MR Finger-
printing (MRF). This new method, Selective Encoding through Nutation and Fingerprinting (SENF), completely
eliminates the need for B0 gradients and is compatible with a wide range of magnet designs and ﬂexible ac-
quisition strategies. Unlike previous B1+ imaging methods, SENF places no strict spatial variation requirements
on the RF gradient ﬁelds, which enables ﬂexible system design, and the same coils can be used for spatial en-
coding and signal reception. Furthermore, instead of suffering from errors due to complex spin dynamics during
RF encoding, SENF leverages those dynamics to its advantage to differentiate quantitative tissue parameters.
Successful completion of this project will enable a new generation of cheaper, more accessible, more modular,
and lower-maintenance MRI scanners with quantitative outputs that can be more directly related to disease and
tissue states.

Public health relevance
Project Narrative The hardware components currently used for spatial encoding, excitation, and signal reception in MRI are complex and represent a large portion of the cost and bulk of a scanner. This project will reduce the cost and complexity of MRI by developing a single integrated coil unit that performs all three of these functions, and is wireless, compact, and scalable. Arraying the units around the body and coordinating their operation using novel pulse sequences will enable rapid quantitative imaging with a wide range of magnet designs and could bring about a new generation of simple, compact, modular, and low-maintenance MRI scanners.